From one end to the other: dynamics of human translation initiation and its control

Project Summary
Protein synthesis begins via a multi-step and highly-regulated process that culminates with a ribosome poised
at a start site on a messenger RNA (mRNA). Loss of control is broadly implicated in human disease, including
cancers, developmental disorders, neurological diseases, and viral infections. Since translation initiation is rate
limiting, an important regulatory strategy involves multi-protein complexes recruited to the opposite end of the
mRNA. Recruited regulatory proteins directly enhance or inhibit assembly of the initiation machinery on the
mRNA, thereby tuning protein production up or down. Many molecular mechanisms that underlie translation
initiation and its long-range control remain unclear. Current paradigms rely on analyses of complexes that are
stable for minutes to hours, as the intrinsic dynamics challenge approaches in bulk solutions. Here, I build off
my initial postdoctoral research to track the human translation initiation machinery, mRNA, and regulatory
complexes as they interact using single-molecule spectroscopy and purified components in vitro, which I
complement with structural analyses. In Aim 1 (K99), I focus on how the ribosomal subunits are recruited to
and load onto an mRNA, and determine how these landmark initiation events are dictated by mRNA features.
In Aim 2 (K99), I examine how the final initiation steps and the transition into active protein synthesis are
coordinated and governed by a universally-conserved GTPase, eIF5B. In Aim 3 (R00), I leverage the obtained
training and expertise to examine how translation initiation is controlled via the 3’-end of the mRNA by the
CCR4-NOT complex, a major regulator with human-health relevance. As my preliminary data demonstrate, my
strategy will overcome previous roadblocks to provide a dynamic view of key molecular branchpoints that
underlie translation initiation, reveal how they are targeted for control, and may define molecular bases of
disease. Aided by strong collaborations and my mentoring team, the proposed research and training plan will
provide me with new conceptual and experimental expertise in structural biology and biophysics and enhance
my professional development. Together, this proposal will serve as a strong foundation as I transition into
independence and continue my investigation of translational control and how it goes awry in human disease.

Public health relevance
Project Narrative Cells must control when and how much of a protein is made; dysregulation leads to human disease. The start of translation, which defines the protein to be synthesized, is the rate-limiting step and therefore is targeted by regulatory complexes that tune protein production up or down. Here, I apply biochemical, biophysical, and structural approaches to illuminate molecular mechanisms that underlie translation initiation and its control – a pillar of human cellular function.